Zebrafish International Resource Center, Applied Research Core

APPLIED RESEARCH ABSTRACT
The Zebrafish International Resource Center has been established as a repository that provides animals,
materials, and services to the research community. The Applied Research Core will research feeding
strategies for commercially available and laboratory defined standard reference diets and we will determine the
long-term effects of diets, feeding regimen, and an optimized protein:lipid ratio on zebrafish husbandry. These
goals will support ZIRC and research community husbandry goals